Revision ACL Reconstruction: A Comparative Effectiveness Treatment Study

PROJECT SUMMARY/ ABSTRACT
Revision anterior cruciate ligament (ACL) reconstruction represents an infrequent but clinically important
challenge in orthopaedic practice. It is commonly reported that the results of revision surgery remain inferior
to primary ACL reconstructions, while the etiology of these poorer outcomes compared with primary
reconstructions remains unknown. With this in mind, the Multicenter ACL Revision Study (MARS) group was
established as an 83-surgeon multicenter consortium to perform a prospective longitudinal cohort analysis of
revision ACL reconstruction outcomes. This is a mixed group of academic and private practice physicians
and has been supported and endorsed by the American Orthopedic Society for Sports Medicine (AOSSM).
Over 1,200 patients were enrolled and have now been followed beyond ten years.
Our previous grant built on previous 2 and 6-year follow-up and obtained 10-year follow-up on the entire
cohort (patient-reported outcome measures and incidence of subsequent surgeries), as well as collecting 10-
year onsite follow-up within a nested cohort for radiographic and clinical measures. Radiographic onsite
follow-up demonstrated structural post-traumatic osteoarthritis (PTOA; Kellgren-Lawrence grades 3-4) in 56%
of the onsite cohort. Previous meniscectomy proved to be a predictor for this severe structural OA, but 60%
did not have a previous medial or lateral meniscectomy. Thus, this proposed grant will utilize genomics
targeted for OA predictors to seek to determine a more comprehensive risk profile for patients for symptomatic
and structural PTOA. Predictors of risk will guide revision surgical decisions and post-surgical activity and
lifestyle guidance, as the spectrum of resulting PTOA may be influenced by genetic variation. Additionally,
predictors and outcomes for total knee arthroplasty in these young active patients will be assessed. Validated
patient-reported outcome measures will assess outcome at 20 years with analysis for predictors to continue
to build upon 2, 6 and 10-year follow-up in order to shape the care of these challenging patients.

Public health relevance
NARRATIVE / RELEVANCE Revision anterior cruciate ligament (ACL) reconstruction results in inferior outcomes compared with primary reconstructions, thus limiting individuals from returning to their previous activities. This multicenter, multi-surgeon prospective study will allow determination of the long-term clinical predictors of outcomes following revision ACL reconstruction. Identifying risk predictors will guide revision surgical decisions and post-surgical activity and lifestyle guidance, as strategies to predict, modify and decrease this risk will change patient’s lives.